PRE AND POST TRANSPLANT DST/CSA IN NON HLA IDENTICAL DONOR KIDNEY TRANSPLANTS

Effectiveness of donor specific transfusion and cyclosporine in inducing donor specific unresponsiveness in kidney transplant recipients.